Nurse Led Telephonic Care

PROJECT SUMMARY
The emergency department (ED) is often the care setting of last resort, and is ill suited to provide care for
people living with dementia (PLWD) and their care partners. Many ED visits, which are for ambulatory-care-
sensitive or acute exacerbations of chronic conditions, pain, behavioral and psychological symptoms of
dementia (BPSD), and care partner strain are addressable if intervened upon in the community. Significant
inequity in access to effective outpatient or home-based care further exacerbates who unnecessarily ends up
in the ED. ED visits are also a significant indicator for serious illness in PLWD; 43.1% will have subsequent ED
visits and 31.9% will die within one year. Telephonic nurse-led, interdisciplinary transitional and palliative care
is a cost-effective, patient centered modality shown to both reduce inequities and ED visits. Studies in both
palliative care populations and earlier stages of AD/ADRD without serious illness showed efficacy. However,
this work has not focused on those living with Alzheimer’s Disease and Alzheimer’s Disease-Related
Dementias (AD/ADRD) who are also seriously ill, on large scale “real-world” embedded pragmatic clinical trials,
or with a focus on the ED as site of triggering telephonic care. This project will implement Aliviado Dementia
Care-Telephonic Edition, an evidence-based nurse-led telephonic transition and palliative care intervention
tested end-to-end and widely disseminated in other modalities. The intervention will follow PLWD for 6-months,
and focus on care transitions, assessing and managing BPSD, care partner strain, social determinants of
health and social needs, and conversations about serious illness. In this study, the nurse-led telephonic
intervention will first be optimized for use in conjunction with the two other interventions used in this proposal
(ED Care Redesign and Community Paramedic-led Transitions) in two EDs to ensure effective coordination
when multiple interventions are used. This optimization will follow a user-centered design process and engage
a wide spectrum of stakeholders in coordination with administrative and implementation cores (Aim 1). We will
then conduct a 3-arm embedded pragmatic multifactorial cluster randomized trial that uses Medicare claims
data to test whether nurse-led telephonic care for PLWD alone and in concert with the other interventions
reduces ED visits and hospitalizations, and increases the number of healthy days at home (Aim 2). We will
implement the intervention in 40 EDs in the larger pragmatic trial, tested alone and in conjunction with the other
interventions in a randomized fashion. We will also examine patient- and organization-level factors, including
health inequities that influence implementation and PLWD- and care partner-reported outcomes as part of a
separate implementation analysis (Aim 3). Upon successful completion, this study will provide stakeholders
with the effectiveness data, as well as the implementation and PLWD-Care Partner dyad factors needed to
provide this highly disseminable and implementable form of dyad-centered care with the potential to improve
quality of care and quality of life, and reduce avoidable healthcare utilization in seriously ill PLWD.